Using markers to improve pancreatic cancer screening and surveillance: a multi-center study

Abstract
Patients diagnosed with Stage I pancreatic cancer have a much better outcome than most
patients who present with advanced disease. The Cancer of the Pancreas Screening (CAPS) study
currently follows a familial/genetic “high-risk” cohort of ~1500 patients undergo regular pancreatic
surveillance. Recent results from the CAPS program indicate that most patients who maintain regular
surveillance are down-staged, many are diagnosed with Stage I pancreatic cancer and achieve
long-term survival. Circulating tumor marker tests are not currently used for pancreas surveillance,
but we propose to evaluate blood tests for patients undergoing pancreatic surveillance. We
will evaluate the use of tumor marker gene tests to better define an individual’s tumor marker normal
reference range. We will evaluate the use of plasma MR spectroscopy as a diagnostic test that
utilizes artificial-intelligence methods to detect subtle circulating metabolic changes associated with
having pancreatic cancer. We will also determine if blood biomarker changes occur before the
diagnosis of pancreatic cancer in our cohort. The addition of annual blood tests to pancreatic
surveillance is expected to improve the detection of early-stage pancreatic cancer. We will continue
to evaluate the long-term outcomes of patients in our cohort and bank biospecimens for future
biomarker studies.

Public health relevance
Project Narrative Pancreatic cancer is the deadliest of the common cancers and one of commonest causes of cancer death. Detecting pancreatic cancer at an early stage greatly improves survival from pancreatic cancer. We propose to evaluate a tumor marker gene blood test for pancreatic cancer early detection in a clinical trial and to evaluate other promising tests aimed at improving the early detection of pancreatic cancer in patients with an increased susceptibility undergoing pancreatic surveillance.